2022 Human Genetic Variation and Disease GRC and GRS

Project Summary
The breadth and complexity of human variation is one of the great scientific and medical challenges of our time.
Modern sequencing technologies now enable detailed measurements of germline and somatic alterations, many
of which underlie human disease. Variants can be characterized by their locations in genomic DNA, evolutionary,
physicochemical, structural, and functional properties, as well as by their effects on RNA transcripts, proteins,
molecular interactions. Ultimately, we must find new methods to measure quantitatively their impacts on human
cells, tissues and lives.
To address this fundamental challenge in 2022, this fifth Human Genetic Variation and Disease Gordon
Research Conference will bring together leading researchers and clinicians from system biology, genomics,
computer science, molecular biology, medical geneticist, population geneticist, data science, biophysics, and
experts in health informatics who will discuss over 6 days the interpretation of genetic and genomic variants at
the DNA, RNA and protein levels. This edition, however, will significantly expand its clinical scope to ensure the
timeliness and importance of the meeting. We will now twin the technical focus on diverse variations typical of
this meeting to their explicit impact on the immune system, the COVID pandemic, interactions with the
microbiome, proliferative disease and early onset diseases, with each of these conditions being addressed in
their own dedicated session. Each session will feature speakers at the frontlines of algorithmic advances to
analyze big data who also interpret their results in these specific clinical areas. This will reflect the increasing
translational relevance of basic computational biology now that high throughput variant data are being gathered
on a massive scale across vast human cohorts (All of Us, the UK biobank, for example) and causing a paradigm
shift in each of these clinical themes. This new design will systematically enable timely and critical assessment
of the state of the art for variant interpretation in each disease area. Our meeting will be unique in the way it will
compare and contrast diverse methods that address different variants in different patient contexts. This will put
participants in a privileged position to reassess the current state of the field and guide the future of this expanding
field based on careful exposition and critical discussion of evidence.

Public health relevance
Narrative The Gordon Research Conference and Seminar on Human Genetics Variation and Disease will accelerate cutting edge research in the integrative interpretation of genome variants and their impact on our health. The meeting will bring together scientists from multiple disciplines and career stages to discuss how advances in systems biology, computer algorithms that leverage big data, electronic medical records, and genomics are being combined to make dramatic improvements across clinical domains in precision health care. For example, multiple speakers and a dedicated session will address the computational analyses of host-genomic variations and to assess COVID-19 risk.